Uncovering spatio-temporal, mechano-transcriptomic signatures of development

Contact PI: Dumitrascu, Bianca
PROJECT SUMMARY/ABSTRACT
Embryonic development requires the complex coordination of molecular, cellular, and
mechanical processes across spatio-temporal scales. Specialized gene expression programs
are established, and cellular aggregates generate force, thus exhibiting synchronized movement
resulting in major self-organizing events such as heart looping or neural tube folding.
Dysregulation at any level can lead to developmental defects and lethality. Yet, it is unclear how
gene expression, cell morphometrics, and tissue-level mechanics work together to accomplish
cell type diversity and inform shape. The goal of my research program is to understand the
interaction between genomics, morphology, and mechanics by disentangling their contribution to
coordinated cellular movement in developmental contexts. Despite the crucial role of cell
morphometrics and tissue-level mechanics in development, methods for rigorously quantifying
and exploring these data types jointly are currently lacking. During this award, we will fill this gap
by: i) identifying gene expression programs that are predictive of tensional dynamics in
multi-species, spatio-temporal contexts and ii) inverse engineering the spatio-temporal
distribution of tensional profiles inferred from microscopy data to evaluate how feedback from
gene programs shapes tissues. To do so, we innovate through the building of an integrative,
statistical machine learning framework for 4D mammalian development, leveraging tools from
computer vision, differential geometry, factor analysis, and graph neural networks, to assess the
interplay between genomics, morphology, and mechanics. We take a multi-species approach,
using data from mouse, fly, frogs, and zebrafish, to identify principles of self-organization shared
across biological systems, with eventual relevance to processes leading to understanding
human disease. More broadly, these techniques will allow us to generate a first computational
framework for understanding how the physical properties of individual cells and their
environments determine self-organization, development, and regeneration in multi-cellular
contexts. We expect that this framework will lead to novel experimental design approaches for
controlling pattern formation and generating tissues that fold according to predefined shapes.

Public health relevance
Contact PI: Dumitrascu, Bianca PROJECT NARRATIVE Tissue morphogenesis is a spatio-temporal process resulting from coordinated changes in gene expression, cellular morphology and the ability of cells to generate and interpret force. The work we propose will provide a computational and mathematical language to understand how cells use gene expression and tension to guide shape changes through directed cellular movements. Our multi-specie approach will uncover general principles of self-organization which may be leveraged to design optimal experiments for improving wound healing and regeneration.